The Impact of BBTI on Cognition and Sleep Health in Older Adults with HIV

Abstract
Approximately 70% of people with HIV (PWH) will be age 50 or older by 2030. Poor sleep and
neurocognitive impairment are commonly reported in PWH and older adults. HIV and age-related changes in
sleep patterns are associated with neurocognitive impairments. This can be detrimental for people aging with
HIV given nearly half the population report mild to moderate forms HIV-Associated Neurocognitive Disorder
(HAND). The impact of poor sleep on cognition in older adults with HIV may increase the risk for
neurodegenerative disorders such as Alzheimer’s Disease (AD). Brief Behavioral Treatment for Insomnia
(BBTI) focuses on sleep restriction and stimulus control and has shown efficacy in improving insomnia in
several populations including middle-aged adults with HIV. Similarly, Brief Mindfulness Therapy (BMT) includes
meditation and breathing exercises and has demonstrated improvement in insomnia in PWH. This study will
examine BBTI versus BMT efficacy on sleep and neurocognitive outcomes in older PWH. The overarching
hypothesis is that BBTI (compared to BMT) will yield greater improvement in sleep outcomes, and sleep
outcomes will correlate with neurocognitive outcomes in older PWH. This study, a randomized single blind
design with experimenter blinding, has three aims. Aim 1: Examine the effects of BBTI versus BMT on
subjective and objective sleep outcomes in older PWH up to 1-year post-treatment. We will randomly assign
214 PWH (age 50+) with insomnia to receive either BBTI or BMT (control) via telephone for four weeks (once a
week for 30 minutes). Subjective insomnia assessments and 7-day actigraphy will be conducted at baseline,
post BBTI/BMT, and 1-year post-treatment. Aim 2: Examine the effects of BBTI versus BMT on neurocognitive
outcomes in older PWH and insomnia. The Delis-Kaplan Executive Function System will assess executive
function, the Repeatable Battery for the Assessment of Neuropsychological Status will assess five
neurocognitive domains (immediate memory, visuospatial, language, attention, and delayed memory), and the
Patient’s Assessment of Own Functioning will measure self-report of cognition at baseline, post BBTI/BMT,
and 1-year post-treatment. Aim 3: Explore the relationship between AD biomarkers and subjective and
objectives sleep and neurocognitive outcomes in PWH receiving BBTI versus BMT at three timepoints
(baseline, post, and 1-year post-treatment). Study findings will expand existing research on BBTI as an
effective nonpharmacological sleep intervention for older PWH. Furthermore, this study lays the foundation for
programmatic research that examines BBTI effects on cognition and AD risk in adults aging with HIV.

Public health relevance
Project Narrative This project is aligned with The National Institute of Aging’s research priorities to examine effective interventions to address HIV and age-related comorbidities such as Alzheimer’s disease (AD) risk. Poor sleep quality is a public health concern which negatively impacts neurocognitive function in adults aging with HIV. A Brief Behavioral Treatment for Insomnia (BBTI) has demonstrated efficacy in improving sleep, and sleep improvements may be associated with better cognition and reduced AD risk in people with HIV as they age.